Characterization of the RRS: a new chromosomal structural element in E. coli

Project Summary/Abstract
Bacterial chromosomes are highly structured in order to accommodate their large size in a relatively small
cellular package. In E. coli, the chromosome is divided into 31 chromosomal interaction domains (CIDs) and
several larger and topologically isolated macrodomains. The structures defining macrodomain boundaries are
unknown. One macrodomain of about 1 million bp encompasses the replication terminus and is referred to as
the Ter macrodomain. We have discovered two 222 bp and intergenic repeat sequences in the E. coli genome,
symmetrically arranged around the replication terminus and just outside what has been defined as the Ter
macrodomain. These sequences, now called replication risk sequences or RRS, trigger unusual levels of RecA
deposition in local single-stranded gaps. The RRS affect replication and are highly conserved in enterobacteria,
including many pathogens. Deletion of one RRS generates a growth defect. It has not been possible to delete
both RRS, suggesting that the retention of at least one of them is essential. The RRS represent a new genomic
phenomenon and likely represent a chromosomal structural feature involved in genomic replication,
condensation, segregation, or all three. We hypothesize that the function of RRS is to relieve topological stress.
The RRS may represent the physical reality of the Ter macrodomain boundaries. Given a complete lack of
information about RRS, we are proposing a general characterization to understand their effects on replication
and transcription. The methods include a variety of standard genetics, microscopy, cell biology, molecular
biology, and genomics. Nonstandard methods include a newly devised genomics method that allows the
probing of genomic single-stranded DNA called ssGAP-seq and single molecule replication assays carried out
in vitro. The goal is basic understanding of the role of RRS in bacterial nucleic acid metabolism to inform future
work.

Public health relevance
Project Narrative The development of new antibiotics requires a complete understanding of bacterial physiology and metabolism, particularly aspects that are unique to bacteria. We have discovered two unusual repeated sequences, called replication risk sequences or RRS, in the chromosome of Escherichia coli that play a demonstrably important role in DNA replication and cell division. As a new DNA structure that is conserved in many pathogens and unique to bacteria, a better understanding of RRS structure and function may lead to new approaches to the control of bacterial diseases.